Integrin signaling in skeletal muscle regeneration

PROJECT SUMMARY Within the skeletal muscle, Pax7+ satellite cells (SCs) are a quiescent muscle stem cell population that becomes activated upon injury and gives rise to progenitors that migrate, divide, and fuse to generate new muscles. Our understanding for these processes during muscle regeneration is incomplete. The central hypothesis of this proposal is that SCs utilize integrin signaling for specialized functions. SCs are located on the muscle fiber surface and surrounded by the extracellular matrix (ECM). The primary ECM binding receptors on the cell surface are the integrin heterodimers, composed of one a-integrin and one β-integrin. Integrins anchor cells to the ECM and tether to the actin cytoskeleton. Upon binding to the ECM, integrins signal intracellularly, frequently in concert with growth factor receptors. SCs express many integrins, and they need to be studied systematically to understand SC biology. This proposal is the beginning of a long-term plan to explore how integrins integrate themselves into specific aspects of SC function: Aim 1: To tease out β1-integrin-regulated signaling in SC function: We will determine how β1-integrin's downstream effectors enhance SC proliferation and self-renewal, via cooperation with FGF2, and potentially with Wnt7a. Aim 2: To determine the role of β3-integrin in SC function: Both β3- and β1-integrins can form receptors for the ECM component fibronectin, which has a role in muscle regeneration. We will determine β3-integrin's function in the SC. Aim3: To determine the role of ILK in SC function in vivo: ILK (integrin linked kinase) is present at the basal membrane of SCs as β1-integrin. We will decipher the role of ILK in the SC. We will also determine whether and how ILK plays a role in integrin-FGF2 synergy in SCs. .

Public health relevance
PROJECT NARRATIVE: We are interested in how integrin signaling regulates muscle stem cell function. Our recent study of β1-integrin in the muscle stem cell reveals its essential role for stem cell aging, quiescence, proliferation, self-renewal, migration, and cell fusion. To gain in depth understanding of integrin signaling, we propose to investigate the role of β3-integrin and integrin linked kinase in muscle stem cells. Results from our research should provide insight into how integrin signaling controls muscle stem cell function, and potential therapeutic targets to enhance muscle regeneration.